Vanderbilt Alzheimer's Disease Research Center: ORE

PROJECT SUMMARY – OUTREACH, RECRUITMENT, & ENGAGEMENT CORE
The Vanderbilt Alzheimer’s Disease Research Center (VADRC) Outreach, Recruitment, and Engagement
(ORE) Core is designed to increase participation and inclusion in VADRC studies, which characterize the
intersection of vascular burden on Alzheimer’s disease (AD) and related dementias (ADRD) at the cellular,
systems biological, and population levels. The ORE Core aims to serve the Nashville, Middle Tennessee, and
broader community by developing community partnerships, increasing equitable access to research
opportunities, and disseminating resources and education. The ORE Core will contribute to the VADRC’s
mission and national ADRC program efforts by improving equitable representation, engagement, and cross-
cultural interactions in ADRD research. We will continue to build strong community partnerships through our
Community Advisory Council and community focus groups, with a focus on centering their perspectives in the
prioritization, design, and implementation of VADRC activities. The ORE Core will continue to advocate for
ADRD research participation and recruit new participants to our Clinical Core and affiliated studies.
Recruitment strategies will include (but are not limited to) community-based events, print and digital media, and
a clinic-based referral pipeline. Importantly, given the higher burden of both ADRD and vascular risk factors
among Black/African American older adults, with disparities even more pronounced in our local region, all
engagement and recruitment efforts will have a special focus on increasing engagement with ADRD research
in the local Black/African American community. All participant engagement, recruitment activities, and
outcomes will be tracked in real time using our Participant Information and Tracking Coordination Hub tool.
This tool will allow the ORE Core to easily facilitate referrals to other investigator-initiated studies and clinical
trials. The ORE Core will provide educational programming and support structures for the community, including
educational seminars focused on vascular risk and ADRD detection, community screening programs for
memory concerns and vascular risk factors, and support groups for individuals and families impacted by
ADRD. Finally, the ORE Core will offer programming within the VADRC to improve the cultural humility and
cross-cultural interactions of all staff, faculty, and trainees.